Development Research Program

The developmental funds portion of our SPORE has proven to be one of the most vital aspects of our translational work in lung cancer. As will be detailed below, over the duration of the SPORE, several of our most productive full projects began as pilot projects funded through this Developmental Program. Also, this program has made possible the initiation of academic careers for multiple translational investigators who are now key players in this and other SPORES. It has also brought basic investigators to lung cancer research who might not have ever worked on these diseases. Finally, as will be evident below in the full presentation of three planned projects for the current proposal, we have used the Developmental Program mechanism to bring innovative new concepts and technology into the SPORE to foster our highest translational aims.